Synthetic 3D Model of the Carotid Artery to Study Exercise-Induced Changes in Endothelial Gene Expression

Abstract
Dr. Samuel Montalvo is a US citizen from Hispanic (Mexican) heritage. Originally from El Paso, Texas, Dr.
Montalvo has earned his Bachelors, Masters, and PhD degrees from The University of Texas at El Paso and
he is a great candidate for this Research Supplements to Promote Diversity application. Dr. Montalvo will work
under the parent grant entitled “Synthetic 3D Model of the Carotid Artery to Study Exercise-Induced Changes
in Endothelial Gene Expression” (SC2GM140952) awarded to Dr. Alvaro Gurovich, which main purpose is to
develop a 3D synthetic model of the human carotid artery using 3D bio-printing technology to simulate
in vivo personalized AX-induced blood flow patterns and endothelial shear stress and to determine
gene expression/transcription and molecular changes in endothelial cultured cells in vitro. Dr. Montalvo
will work in 3 studies, 2 of them associated with the parent grant specific aims that hypothesize that a 3D
synthetic model of the carotid artery will respond to exercise-induced blood flow patterns as a normal carotid
artery (Specific Aim 1) and that endothelial cultured cells under similar blood flow patterns and shear stress will
increase the expression of atherosclerosis-protective mRNA/proteins (e.g., eNOS, PGI2, and SOD) and
structural mRNA/proteins (e.g., actin, heparin sulfate proteoglycan [glycocalyx], and α-actinin-bundled stress
fibers), and a decrease of pro-atherosclerosis and pro-inflammatory mRNA/protein expression (e.g., ICAM-1,
VCAM-1, and ET-1) in a similar intensity-dependent manner (Specific Aim 2). The third study is a parallel study
responding to some of the comments from the reviewers of the parent grant. The purpose is to determine the
differences between the traditional 2D shear stress model and the novel 3D synthetic model proposed in the
parent grant. To accomplish this purpose, Dr. Montalvo will work with collected data to develop the pilot 3D
model and compared protein/gene expression in endothelial cells under shear stress in the 2D and 3D models.
He hypothesizes that the 3D model will be able to increase endothelial cell protein content as the 3D is more
physiological to endure higher shear stress as the ones observed during high intensity exercise. In addition, to
the research projects proposed, Dr. Montalvo will have a strong mentorship plan including 4 mentors in
different career stages (i.e., lecturer, Assistant, Associate, and Full Professors). The parent grant, the specific
research projects, and the mentorship plan and team will enhance Dr. Montalvo’s research capacity and
increase his chances to obtain a tenure track faculty position in a research institution.

Public health relevance
Parent Grant Project Narrative The present study will unveil direct mechanisms to improve endothelial function via La-derived AX. In addition, these mechanisms will help confirm that personalized AX is good medicine and that stroke survivors could benefit from it. Furthermore, the present study will justify, at the molecular/epigenetic level, the inclusion of stroke survivors to cardiovascular rehabilitation programs, which are administered by several health professionals such as nurses, physical therapists, and clinical exercise physiologists.